Administration Core

PROJECT SUMMARY/ABSTRACT ? Administrative Core The Administrative Core of the Berghia Brain Project will support multi-disciplinary research, aid in the dissemination of research findings, and foster team-building, synergy, and integrative capacity among participants. The Administrative Core will also evaluate all Projects and Cores, to ensure success of the Berghia Brain Project. It will create and manage a process to coordinate research activities using innovative internal communication channels. The Administrative Core will develop and implement financial and human resources policies and procedures and evaluate all Berghia Brain Project activities.